Obesity-mediated protection in sepsis

ABSTRACT
Sepsis is a major burden to the healthcare system being the most common cause for admission to the intensive
care unit and the most expensive condition treated in US hospitals. It is a complex physiologic condition involving
a heterogenous patient population with high morbidity and mortality, and no specific therapies aside from
supportive measures. Clinical studies indicate that obesity is paradoxically associated with improved survival in
sepsis; however, the mechanisms behind this obesity-mediated protection are not known. Capitalizing on the
unique resistance in this patient population may allow for the development of novel therapies to prevent the
morbidity and mortality associated with sepsis. The primary goals of my research program are to 1) investigate
differences in sepsis pathophysiology in patients stratified by obesity status with a major focus on immune
alterations, and 2) define shifts in immune cell function and metabolism in obesity, and determine their roles in
conferring protection during sepsis utilizing a validated murine model and patient samples. The gained
information will aid in the development strategies to reduce morbidity and mortality in sepsis.

Public health relevance
PROJECT NARRATIVE Obesity is paradoxically associated with improved survival during sepsis; however, the mechanistic basis for this protection is not understood. This project will investigate alterations in immune cell phenotype, function, and metabolism during sepsis in patients and rodents with underlying obesity.